Cancer Research Training and Education Coordination

CANCER RESEARCH, TRAINING, AND EDUCATION COORDINATION (CRTEC)
PROJECT SUMMARY/ABSTRACT
The future success of cancer research depends upon the successful personal and professional development of
the next generation of diverse teams, steeped in disciplinary excellence, expertly mentored, and supported by
institutional organizational structures and programs. Career-long support encourages multi-lingual and multi-
cultural collaboration, with timely access to resources inclusive of all members of the workforce. The UC Davis
Comprehensive Cancer Center (UCDCCC) culture has long focused upon workforce development and offers a
remarkable spectrum of cancer training and career development opportunities coordinated across the trainee
spectrum: high school and undergraduate students, post-doctoral trainees, junior faculty, and mentors in order
to enhance education, training, and/or mentorship skills. Since 2019 CRTEC has coalesced into an
organizational hub, a component that provides comprehensive, integrated support across the UCDCCC, the
entire university, and external partners to successfully implement its vision. UCDCCC has established an
Office of Education, Training, and Career Development under the supervision of the Cancer Center’s AD for
Education, Training, and Career Development, Dr. Fred Meyers. This Office is managed by UCDCCC’s
Administration and is coordinated by Ms. Kirsten Asher who works closely with Dr. Meyers in executing
programmatic efforts. Early metrics of success of this strategic organizational alignment include the recent
award of the only Comparative Oncology T32 training grant in the country, a UCD wide F award workshop, a
new collaboration with the CSUS School of Education focused on high school teacher cancer and data
sciences curriculum development, UCDCCC Grand Rounds, a Mentoring Academy for Cancer Research, and
two advisory councils that facilitate the voices of diverse stakeholders to be heard in programmatic
development. Each UCDCCC Research Program and SR is accountable for and has strengthened their
CRTEC activities. CRTEC is well supported by the UCDCCC and UCD, including the SOM Dean’s recent
commitment to fund salary differentials above the NIH cap for K awardees. CRTEC is engaged across the
entire university by embedding UCDCCC members in the leadership of formal training programs, including
extramurally funded efforts; participation by UCDCCC members in lectures, seminars and workshops offered
within these programs; participation of UCDCCC members as trainers or mentors in training programs;
listening to stakeholders through the Education and Training Council; and providing cancer-relevant
educational and training opportunities.